Recording Spinal Neural Activity Across Genetic Classes During Hindlimb Motor Behaviors

Project Summary/Abstract:
The spinal cord is comprised of many genetically and functionally heterogenous cell types that are both
interconnected and intermingled to form complex circuits for computing limb movements. From a computational
perspective, motor control represents an enormous challenge because even the simplest motor actions require
precise coordination of muscle contraction timing and force across joints that have multiple degrees of freedom.
The goal of this grant is to characterize the firing patterns of spinal neurons during motor behaviors while
characterizing their spatial relationships, functional-connectivity, and genetic profile in order to better understand
how the spinal cord processes motor commands for meaningful limb movements. The experiments in this grant
are based on a technical breakthrough in which highly-flexible nano-electronic thread (NET) probes with 32,
64x2, and 128 recording sites have been optimized for monitoring neuronal activity in the spinal cord of awake
behaving mice. This grant is a multi-PI collaboration that builds on the strengths of three laboratories with
expertise in engineering, physiology, and neurogenetics that have a record of productive collaboration.
Models of spinal motor circuitry often conceptualize the system as modules, with components dedicated for
rhythmicity (central pattern generation, CPG), pattern, and/or extensor-flexor regulation. Preliminary studies
have uncovered evidence that individual spinal neurons participate in controlling multiple distinct motor actions.
Moreover across different motor behaviors the functional-connectivity between the same active neurons
changes. These observations have led us to hypothesize that the spinal neural network operates as a multi-
functional system using overlapping neuronal sets to generate different motor commands. Thus, motor
information appears to be encoded by the relative pattern of neuronal activity in the ensemble rather than
dedicated separate circuits for each muscle.
Defining how spinal circuits compute limb movements has remained challenging because the relationship
between the activity, connectivity, and genetics of locomotor neurons remains very fragmentary. To address this
Aim 1 will record and map lumbar spinal neuron activity and position during a range of hindlimb movements to
determine if (1) neurons display multi-functional properties across behaviors, and (2) determine whether there
are focal or diffuse spatial distributions of cells linked to specific features of motor control. Aim 2 will use
innovative multi-shank electrodes to record spinal interneurons and motor neurons and define the dynamical
functional-connectivity relationships within the network during different behaviors. Aim 3 will use mouse genetics
to record genetically-defined spinal interneurons (Satb2+ MSE neurons; En1+ V1 neurons; and Chx10+ V2a
neurons) identified using optotagging, in order to examine the heterogeneity within each class and define
whether there are common properties shared by genetically-related cells. These studies will expand current
understanding of how spinal circuits transform descending and sensory inputs into ethological motor behaviors.

Public health relevance
PROJECT NARRATIVE The spinal cord contains local circuitry that drives coordinated patterns of motor pool activity to produce motor behaviors. In this grant the investigators will use innovative flexible multielectrode arrays to characterize the activity patterns of specific interneuron subclasses controlling hindlimb movements in awake behaving mice. These experiments will provide insight into the function of complex multicellular circuits that integrate volitional and sensory information, and provide a foundation for directing the repair of spinal cord injuries.